Prognostic Indices for Hospitalized Older Adults with and without Alzheimer’s Disease and Related Dementias

Project Summary/Abstract
We will develop and externally validate electronic health record (EHR)-based prognostic indices to improve
healthcare quality for hospitalized older adults by identifying patients most likely to qualify for (and benefit from)
specific health services. Our indices will predict: 1) 6-month mortality to guide hospice referral decisions; and
2) 2-year mortality to guide outpatient palliative care referrals and inform medication deprescribing. We will
develop each of these indices for patients with and without Alzheimer’s disease and related dementias, since
previous studies suggest that the trajectory of decline differs between older adults with and without Alzheimer’s
disease and related dementias. Function is critically important to prediction in older adults, particularly those
with Alzheimer’s disease and related dementias, and we have shown that the prognostic power of function
increases with age. A major limitation that has hindered the effectiveness of predictive indices for hospitalized
older adults has been the lack of functional data in the EHR. Recently, recognizing the critical role of function in
providing high quality healthcare to older adults, hospital systems have started to routinely assess and
document functional status. This development facilitates our proposal since we now have access to routine
functional data from several hospitals, allowing us to incorporate these data into prognostic indices. With EHRs
becoming ubiquitous in healthcare systems, our externally validated indices could be integrated into the EHR
in most hospitals. To facilitate use in hospitals without EHR integration, we will develop parsimonious indices
(also for ADRD and non-ADRD patients) available on ePrognosis, our free and widely used online
compendium of geriatric prediction indices. We will set a new standard for equity-conscious prognostic model
building by “baking equity” into model selection and incorporating neighborhood disadvantage as predictor
representing social determinants of health. We have established a 4 site Collaboratory, which all routinely
collect physical function data, clinical diagnoses, standardized delirium assessments, laboratory values, and
physiologic measures: UCSF & Cleveland Clinic (development cohort); and Beth Israel Deaconess Medical
Center & Johns Hopkins (external validation cohort). We propose to: (1) Develop full prognostic indices
designed to be embedded in EHRs for 6-month and 2-year mortality for hospitalized older adults with and
without Alzheimer’s disease and related dementias; (2) Develop parsimonious web-based prognostic indices
designed to be accessed through ePrognosis for 6-month and 2-year mortality for older adults with and without
Alzheimer’s disease and related dementias; (3) To internally validate the effectiveness of these prognostic
indices; and (4) to externally validate these indices. These indices will help clinicians improve healthcare
quality for older adults by prompting alignment of patient prognosis with health services (i.e. hospice and
palliative care referrals) and deprescribing decisions.

Public health relevance
Project Narrative Short-term mortality prediction is critical to optimizing healthcare quality for hospitalized older adults by identifying which patients are most likely to benefit from which healthcare services (e.g. hospice) and medications (e.g. statins). Unfortunately, we lack high-quality validated prediction tools to help clinicians determine short term mortality risk. The objective of this project is to create prediction tools for estimating short term mortality risk for hospitalized older adults with and without Alzheimer’s disease and related dementias.